Automated System for Accurate Determination of Activities of Daily Living for Independently-Living Persons with Alzheimers Disease and Related Dementias

Project Abstract
In this Phase I SBIR project, ASTER Labs will develop and evaluate an innovative system to automatically and
accurately detect Activities of Daily Living (ADL) performed by persons with Alzheimer’s disease and related
dementias. It will address a current need to equip caregivers and health care providers, including physicians
and cognitive rehabilitation therapists, with reliable information on patients’ ongoing abilities to perform these
important activities. The confirmation of these abilities will directly support the capability of a functioning
independent lifestyle, while producing informed decisions on interventions and level of care based on disease
progression. An estimated 5.8 million Americans in 2020 live with Alzheimer’s dementia. Nearly a third of these
individuals live alone and are more likely to experience poorer health outcomes than cohabitating persons.
Ongoing assessment of ADL is highly recommended for establishing diagnosis of dementia and progression of
the disease over time. Existing and proposed approaches to automate this assessment in the home have
ranged from cameras or vision-based sensors to beacon-based signal processing techniques. However, these
approaches have been subject to limitations and critique due to privacy concerns, poor accuracy, limited
coverage, and requirements of significant infrastructure alterations. Common commercial activity trackers have
concentrated primarily on fitness activities, and typically rely on non-discreet wearable devices that, due to
unfamiliarity, may be unacceptable to dementia patients. Clinical research has indicated interventions involving
compensatory memory techniques and devices may help prevent or delay dementia onset, and preserve
functional independence. Use of both manual and digital memory notebooks to help patients record when they
performed certain activities have shown significant promise. However, seniors with memory impairment and
dementia may risk inaccurate recollection of activities performed throughout the day, and have faced difficulty
interacting with recent digital implementations of these interventions. An unmet need exists in the ability of
those caring for these individuals to receive verifiable information on whether the activity was completed at the
time reported by the patient, or at all. ASTER Labs’ proposed Activlog system leverages intelligent processing
of WiFi, GPS, inertial, and audio sensor data from a small hardware suite concealed in a shoe insole,
unnoticeable to the wearer, that uses high-precision location and multi-sensor association to accurately and
continuously monitor and detect ADL. In Phase I, the prototype system will be assembled, with feasibility
demonstrated by functional evaluation conducted through a focus group study with caregivers, physicians, and
cognitive rehabilitation therapists of patients with dementia. Activity classification accuracy of the device will be
determined in timed experiments by ASTER Labs’ engineers wearing the prototype insoles. Phase I testing will
provide the success criteria for the start of the Phase II program, which will include a human study of the fully-
operational system in home and independent living settings to establish the efficacy of this approach.

Public health relevance
Project Narrative Rapid increases in America’s elderly population suffering from dementia have increased focus on assisting these individuals maintain functional independence, and ongoing assessment of Activities of Daily Living is recommended for evaluating individual patients’ progression of the disease over time. Clinical research has shown the benefits of compensatory memory techniques and interventions involving ADL and other healthy behaviors in helping prevent or delay dementia onset and preserve these functional abilities. The proposed research addresses an unmet need to automatically, accurately, and continuously monitor, record, and verify ADL completion by developing a comprehensive activity detection and determination device, which will equip remotely-located caregivers, physicians, and cognitive rehabilitation therapists with reliable information to promote informed decisions on diagnosis, interventions, and level of care.